Histone Deacetylation Signaling in Aging and Cancer Pathways

Our broad research goal is to understand chromatin regulatory mechanisms in nuclear and epigenetic
programs and how these mechanisms are deregulated in aging and disease. A fundamental mechanism for
regulating chromatin involves the reversible modification of histones by chemical moieties such as acetyl-,
methyl-, and phospho-groups. These different histone marks are linked to discrete chromatin states and
regulate the accessibility of DNA to transacting factors. In budding yeast, histone deacetylation by the
chromatin silencing factor Sir2 prevents genomic instability and aging, and in mammals, de-regulation of
histone acetylation is linked to cellular senescence and aging-related pathologies from neurodegeneration to
cancer. Here, we focus on SIRT7, a chromatin regulatory, lysine deacetylase enzyme in the Sir2 family of
aging-regulatory factors. This project will study new roles of SIRT7-dependent histone deacetylation in
chromatin regulatory mechanisms that are deregulated in aging and age-associated cancer biology.
Inactivation of SIRT7 in mice leads to genomic instability, shortened lifespan and aging-related phenotypes,
and preliminary studies suggest that increased SIRT7 protects against aging pathologies in mice. However,
SIRT7 can also sustain oncogenic transcriptional programming in cancer cells. Thus, uncovering distinct
pathways of SIRT7 chromatin regulation, may be important to dissect pleiotropic functions of SIRT7 in aging
and cancer pathways. Recently, we identified a novel substrate of SIRT7, acetylated lysine K36 of histone H3
(H3K36ac), which is dramatically hyper-acetylated upon SIRT7-inactivation. H3K36ac is implicated in
chromatin remodeling and DNA damage responses in yeast, but its regulation and functions in mammalian
biology are largely obscure. In preliminary studies we found that the increased H3K36 acetylation in SIRT7-
deficient cells is coupled to decreased di-methylation at this residue (H3K36me2), a chromatin modification
that has important roles in gene activation, DNA methylation and oncogenic transformation. Moreover, SIRT7
interacts physically with the oncoprotein NSD2, the enzyme that generates the bulk of H3K36me2 in many cell
types. Here, we will investigate a new model that SIRT7 clears acetylation at H3K36 from large swaths of
chromatin to help prime NSD2-catalyzed methylation at H3K36. In Aim 1, we explore the connection of SIRT7
and NSD2 in aging-related processes using genomic, cellular and mouse systems, and in Aim 2, we test the
role of SIRT7-H3K36-NSD2 methylation axis in driving lung carcinoma in vivo, using pre-clinical mouse and
human cancer models. By uncovering distinct pathways of SIRT7 chromatin regulation, this project may suggst
strategies to selectively enhance functions of SIRT7 that are protective in aging without promoting oncogenic
SIRT7 activities. Together, these studies should provide insights into fundamental chromatin mechanisms in
aging and cancer biology.

Public health relevance
We propose to investigate novel mechanisms of action of the SIRT7 enzyme in regulating chromatin – the structure in which the human genome is packaged – and how these mechanisms are linked to mammalian aging and cancer biology. Defects in chromatin regulation can contribute to numerous aging-associated pathologies, including cancer, metabolic and neurodegenerative disease. This proposal will provide new insights into how chromatin mechanisms regulate important cellular functions, and has the potential to identify new targets for therapeutic intervention.